AUTOMATIC PHOSPHORUS MAGNETIC RESONANCE SPECTROCOPY DATA QUANTIFICATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. House built singular value decomposition based automatic baseline separation and signal estimation algorithm is implemented to test on in vivo phosphorus data.